Asthma: Insights & Expectations. 51st Annual Thomas L Petty Aspen Lung Conference

[unreadable] DESCRIPTION (provided by applicant): [unreadable] [unreadable] N/A [unreadable] [unreadable] [unreadable]